Assessment of microvascular volume in smokers using AI

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) and emphysema are globally significant chronic lower
respiratory diseases that represent a major cause of morbidity and mortality worldwide. COPD is diagnosed via
spirometry, which detects airflow obstruction that is not completely reversible, while emphysema is defined on
pathology as the permanent enlargement and destruction of alveolar walls and can also be measured on
computed tomography (CT). Despite advancements, pharmacologic therapies for COPD lack efficacy in altering
disease progression or improve mortality.
Recent CT imaging studies have highlighted the significance of pulmonary vascular endothelial damage in the
pathogenesis of these diseases. Evidence suggests that the pulmonary vasculature may be significantly
compromised in patients with COPD and emphysema, indicating a fundamental role of pulmonary vascular injury
in disease etiology and progression. However, despite advancement in macro-vascular imaging, understanding
of the microvasculature’s role in COPD progression remains limited. While new imaging modalities have
emerged for detecting microvasculature perfusion, their availability is often limited in large-scale epidemiological
studies, hindering accurate investigations into disease etiology and progression. To address this gap, we
developed an AI-based algorithm for robust assessment of vascular perfusion from single energy non-contrast
CT scans, which enables the definition of novel image-based markers of pulmonary microvasculature alterations
in large epidemiological studies. The proposed research, carried out via a secondary analysis of subjects in the
COPDGene cohort, aims to develop and validate a quantitative marker of pulmonary microvascular injury and to
explore the correlation between microvascular volume loss and the longitudinal progression of COPD and
emphysema in smokers with and without COPD.
In Aim 1, we will extend the validation of our AI-based method for generating perfusion maps from single energy
non-contrast CT scans. Our preliminary analysis on a non-COPD specific dataset demonstrates the
effectiveness and reliability of our approach. As part of Aim 1, we will further validate this technique through a
comparative analysis between our synthesized perfusion maps and dual energy CT perfusion imaging. This
analysis will be conducted using subjects diagnosed with COPD, both with and without PH, for which single
energy non-contrast CT images, DECT scans, and perfusion maps are available.
In Aim 2, we will estimate perfusion information from subjects in the COPDGene Phase 2 study to define a
quantitative marker of microvascular volume. This marker will serve as a tool to investigate the relationship
between pulmonary vascular damage and clinical outcomes, COPD, and emphysema development.
Through these efforts, we aim to create an image-based quantifiable feature of pulmonary vascular injury,
facilitating new research studies on the etiology and evolution of COPD in smokers.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a heterogeneous high mortality lung condition, characterized by airflow obstructions and pulmonary vascular endothelial damage. In the research outlined in the following proposal, we aim to define and evaluate quantitative markers of pulmonary microvasculature injury using non- contrast CT scans and investigate correlations with emphysema development and progression. The results of this work will enhance our understanding of the principal mechanisms underlying pulmonary vascular damage and extend our knowledge of their role in the etiology and progression of COPD and emphysema.